Transforming C. Elegans Research Through Gigahertz Ultrasonic Imaging Microscopy

Abstract
C. elegans is a model organism used for biological research across thousands of US and world labs for
fundamental and transla�onal research. Due to the versa�lity of gene�c manipula�ons and its rela�vely
short lifespan, C. elegans has been essen�al in studying aging, pathogenesis, molecular mechanisms,
gene�cs, toxicology, and compound screening. Several protocols for the cul�va�on, maintenance, and
performance of survival assays of C. elegans have been established and reﬁned over �me. Despite these
advancements, one of the signiﬁcant limita�ons of C. elegans work is the manual eﬀort and handling
required for longitudinal phenotyping. Researchers must manually move adult worms across petri dishes
to avoid confusion with the hundreds of progenies being produced that become adults within days. For a
longitudinal assay, the movement of worms is monitored daily throughout their �ssue degenera�on,
degrada�on, and eventual death. We propose to develop and understand gigahertz ultrasonic imaging of
worms, to reduce the eﬀort involved in worm research, and make the protocols repeatable across
diﬀerent laboratories, while developing a new phenotype for the C. elegans research community.
Geegah has developed a 2D 256x256 25-micron pixel array using 2 GHz ultrasonic transmit/reﬂec�on.
Geegah’s GHz ultrasonic pulses reﬂect with suﬃcient SNR to create images and real-�me movies of
nematodes and C. elegans worms in petri dishes. In preliminary studies, Geegah's GHz ultrasonic imager
has measured and iden�ﬁed ultrasonic impedance diﬀerences between live (mobile, immobile), dead
worms, and across diﬀerent species of worms. The proposed work will ﬁrst understand the GHz
ultrasonic response of the worm anatomy by detailed analy�cal and FEM modeling. These models and
images will be used to develop a phenotype based on ultrasonic maps of cu�cles. Lastly, an automated
prober system will be designed and prototyped, with the end-eﬀector being Geegah ultrasonic imagers,
that can generate digitally annotated maps of worm ultrasonic proper�es and provide live/dead status in
petri-dishes that are regularly used in C. elegans research labs.

Public health relevance
Narra�ve C. elegans is a crucial model animal used in research on Alzheimer’s progression and other aging-related disorders. The improved and reliability of research will also enable researchers to atempt to prove a greater number of hypotheses to accelerate the speed at which our understanding of aging is gained. This project will increase the speed and accuracy with each C. elegans aging assay, which will increase the speed at which new drugs can be developed.